Reconfigure and legacy data transfer of toxicological results. (for OTDC). National Medical Service (NMS) (Toxicology Testing) [17-004996]

The National Institutes of Health (NIH) NeuroBioBank, comprised of the National Institute of Mental Health (NIMH), the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD), and the National Institute of Neurological Disorders and Stroke (NINDS), provides post-mortem human brain tissue for research on neurological, psychiatric and neurodevelopmental disorders. A federation of six brain and tissue repositories comprise the NIH NeuroBioBank and offers a means to coordinate this important research resource through greater standardization and cost savings. As part of the NIH NeuroBioBank effort a laboratory is sought to provide testing for abused, illicit and therapeutic drugs in blood, brain, urine and hair samples from donors. The period of performance is five years from the date of award. These assays will include screens for multiple drug classes/types. The majority of agents to be tested under this program will be drugs of abuse or psychotropic drugs. The Contractor may be required to do a comiantion of assays on a given tissue, or assess a particular drug in several tissue types (e.g. blood, brain, urine and hair) according to the needs of investigators requesting services and NIH NeuroBioBank programmatic priorities.